EFFECTS OF VITAMIN D INSUFFICIENCY IN MAN

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. Define the mechanism of TLR2/1-induced 25D-dependent antimicrobial activity in human monocytes/macrophages